Emerging Technologies & Data Analytics Core

EMERGING TECHNOLOGY AND DATA ANALYTICS PROJECT SUMMARY
The science of behavioral health, and the development of effective interventions in behavioral health, are
increasingly supported by a range of technologies – from sensors that measure physiological conditions and
contextual factors, to algorithms that infer (and predict) an individual’s receptivity to an intervention in the
moment, to analytics that infer behavioral characteristics or individual phenotypes, to real-time classifiers that
drive just-in-time adaptive interventions, to analytic methods to statistically understand multimodal datasets, to
visualizations that sift through terabytes of sensor data, to user-centric design processes that lead to novel
interfaces that are acceptable and usable. Faculty affiliated with the CTBH Emerging Technologies and Data
Analytics Core (ETDA Core), which launched in the last P30 renewal period, have the expertise to address all
these components in this spectrum of foundational technologies.
In this P30 Center renewal application, the ETDA Core will enhance educational and research opportunities
focused on the application of emerging technologies and data analytics to the development and evaluation of
digital therapeutics. The Core will continue our current activities, including expanding the ETDA Core
community, promoting reciprocal learning, assisting with the seminar series, supporting the shared resources
developed during the current P30 period, providing expert consulting, and engaging with the Pilot Core to
sponsor Pilot RFAs that encourage and enable collaborations between ETDA-Core affiliates and CTBH
behavioral scientists. And, the Core will launch new activities, including hosting a tutorial series, contributing to
several research cross-Core workshops, sponsoring a trainee lunch series, expanding its expert consulting,
expanding industry partnerships, expanding international collaborations, addressing challenges of scale,
supporting research aimed at personalized interventions, supporting research on transdiagnostic mechanisms
and interventions, supporting activities related to digital ethics, and expanding efforts to increase inclusion of
underrepresented populations.
The ETDA Core will also support shared resources among our interdisciplinary Center team to enhance the
pace of development, and resulting potency, of digital therapeutics. To this end, the Core will maintain and
expand its pool of shared hardware, maintain and expand its set of group licenses for specialized software,
maintain and refine its home-grown software libraries, develop guidelines and best practices for effective user-
centered design of behavioral interventions, seek permission to obtain and share data sets, and further
develop its staff’s expertise in the creation and management of technology fundamental to operating robust
and scalable behavioral-health studies.